DETECTION OF NEUROTRANSMITTER FLUORESCENCE USING THREE PHOTON EXCITATION

Secretion of neurotransmitters is the primary means by which excitable cells communicate with one another. We have determined three-photon fluorescence cross-sections of monoamine neurotransmitters and neuropeptides, with the goal of investigating the spatial characteristics of neurotransmitter secretion.